CLINICAL RESEARCH AND STUDY MONITORING SUPPORT FOR NIMH STUDIES

The NIMH Office of Clinical Research (OCR) provides institute-wide coordination and oversight for NIMH-funded clinical research studies including strategic guidance and recommendations to NIMH leadership about clinical research initiatives. An important component of the oversight activities involve on-site monitoring of NIMH funded clinical research.